A cutting edge approach to assessing physical activities occurring on sidewalks/streets

Abstract A considerable proportion of outdoor physical activity is done on sidewalk/streets. For example, we found that ~70% of adults who walked during the previous week used the sidewalks/streets around their homes. Interventions conducted at geographical levels (e.g., community) and studies examining relationships between environmental conditions (e.g., traffic) and walking/biking, necessitate a reliable measure of physical activities performed on sidewalks/streets. The Block Walk Method (BWM) is one of the more common approaches available for this purpose. Although it utilizes reliable observation techniques and displays criterion validity, it remains relatively unchanged since its introduction in 2006. It is a non-technical, labor-intensive, first generation method. Advancing the BWM would contribute significantly to our understanding of physical activity behavior. Therefore, the objective of the proposed study is to develop and test a new BWM that utilizes a wearable video device (WVD) and computer video analysis to assess physical activities performed on sidewalks/streets. The following aims will be completed to accomplish this objective. Aim 1: Improve the BWM by incorporating a WVD into the methodology. The WVD is a pair of eyeglasses with a high definition video camera embedded into the frames. We expect the WVD to be a viable option for improving the acquisition and accuracy of data collected using the BWM. Aim 2: Advance the WVD-enhanced BWM by applying machine learning and recognition software to automatically extract information on physical activities occurring on the sidewalks/streets from the videos. Methods: Trained observers (one wearing and one not wearing the WVD) will walk together at a set pace along predetermined, 1000 ft. sidewalk/street segments representing low, medium, and high walkable areas. During the walks, the non-WVD observer will use the traditional BWM to record the number of individuals standing/sitting, walking, biking, and running along the segments. The WVD observer will only record a video while walking. Later, two investigators will view the videos to determine the numbers of individuals performing physical activities along the segments. For aim 2, the video data will be analyzed automatically using multiple deep convolutional neural networks (CNNs) to determine the number of humans in a segment as well as the type of physical activities being performed. Bland Altman methods and intraclass correlation coefficients will be used to assess agreement. Potential sources of error such as occlusions (e.g., trees) will be assessed using moderator analyses. We expect the new approach will enhance measurement accuracy while reducing the burden of data collection. In the future, we will expand the capabilities of the WVD-CNNs system to allow for the determination of other characteristics captured by the videos such as caloric expenditure and environmental conditions. Our long-term goal is to substantially improve the assessment of physical activity and our understanding of physical activity behavior.

Public health relevance
PROJECT NARRATIVE Sidewalks and streets are public spaces where a considerable amount of physical activity occurs. As such, accurate and feasible methods are important for understanding the role these areas play in facilitating physical activity and improving public health. In the proposed study, we will develop and test a state-of-the-art, observation approach using a wearable video device and computer technology to measure physical activities performed on sidewalks/streets. Findings have the potential to significantly impact research in this area and inform the further development of technology-enhanced observation methods for widespread, practical applications that promote healthy lifestyles and reduce chronic disease risks across the age spectrum.